Association of Health Belief Variables, Religiosity, and Spirituality with AC Use in Older Adults with Atrial Fibrillation

PROJECT SUMMARY/ABSTRACT
Six million Americans suffer from atrial fibrillation (AF), a heart rhythm abnormality that contributes to
significant morbidity and mortality. By 2050, the number of Americans with AF is expected to double. AF
accounts for 15% of ischemic strokes, resulting in permanent disability in 60% of cases and death in up to 20%
of cases. Although oral anticoagulation (AC) is effective for AF-related stroke prevention, only 60% of eligible
AF patients use AC. This is particularly true among non-white AF patients, for whom AC use is lower and
stroke rates are higher. Understanding the barriers that contribute to this gap in AC use and adherence is
critical to developing strategies to help decrease AF morbidity and mortality rates in underserved populations.
The proposed Diversity Supplement will allow an outstanding early-career investigator to conduct studies in a
diverse population of individuals over age 65 with AF to examine the barriers to AC use. This work will be a
natural extension of the parent R01 SUPPORT-AF IV: Supporting Use of AC through Provider Prompting
about Oral Anticoagulation Therapy for AF. Now in its third year, SUPPORT-AF IV has already established a
cohort of diverse individuals and their providers from two distinct health systems in Massachusetts and Florida.
The goal of the parent award is to examine the impact of a novel AC clinical decision support tool within the
electronic health record (EHR) on AC prescribing behaviors among healthcare providers and clinician
engagement with the overarching goal of creating an implementation toolkit. Thus, the candidate will have
access to this diverse population to perform vital research while learning essential skills and receiving career
guidance from a supportive mentoring team of experts.
In Aim 1, the candidate will perform telephone surveys to measure the association of health belief variables
(risk perception, trust in providers, beliefs about the effectiveness of AC) + religiosity and spirituality on AC use
in older adults with AF on and off AC and established in care at our participating sites. The candidate will then
perform a subset analysis to measure the differential association of surveyed variables with AC use in African
American and other Black older adults compared with other older adults. For Aim 2, the candidate has
developed a rigorous course schedule and career development plan with her mentor to gain expertise in
survey research methods, implementation science, community engagement research, mixed methods
research, and advanced biostatistics. With her supportive mentoring team and access to UMass Chan’s faculty
development programs (e.g., the UMass Chan K-club) this exceptionally promising candidate will receive
valuable training, opportunities, and research experiences to launch her independent career.

Public health relevance
Project Narrative Six million Americans live with atrial fibrillation (AF), a heart rhythm abnormality that is a major risk factor for stroke, and only 60% of these AF patients take the recommended treatment, anticoagulation (AC). This problem is even worse for non-White patients who are at higher risk of stroke due to AF. The proposed Diversity Supplement will support an outstanding early-stage investigator to examine AC use in a diverse population of older adults while also providing mentoring and training opportunities to establish the candidate as an independent investigator.